The Vervet Research Colony as Biomedical Resource

PROJECT SUMMARY
Vervet monkeys (Chlorocebus aethiops sabaeus) develop age-related amyloid pathology that resembles very
early stages of Alzheimer's disease in humans. Hippocampal hypometabolism and volume reduction occur in
amnestic mild cognitive impairment in humans, a condition characterized by impaired everyday memory which
often precedes development of Alzheimer's disease, but the effect of age on hippocampal function in vervets is
not known. Determining how age and Alzheimer's-related biomarkers are associated with hippocampal
structure and function in vervets would dramatically enhance the utility of this species as a model for age-
related cognitive impairments and early-stage Alzheimer's disease. As a first, exploratory step towards
characterizing hippocampal structure and function in aging vervets, the goal of this application is to develop a
continuous tracking system to monitor locomotor behavior in group-housed vervets in the Vervet Research
Colony at Wake Forest. This will allow us to monitor position within the home environment longitudinally for
long periods of time (weeks to months) and will allow us to determine whether locomotor behavior in aging
vervets displays patterns characteristic of dementia-associated "wandering" in humans. We will also measure
hippocampal volume with structural MRI and metabolic activity with FDG-PET imaging, and Alzheimer's-
related blood biomarkers. This will allow us to explore whether any features of movement around the home
enclosure discriminate between individuals based on hippocampal volume, glucose metabolic rate, or fluid
biomarkers of Alzheimer's disease. Because behavioral readouts of hippocampal function currently are mainly
obtained through prolonged cognitive testing, which is resource-intensive and impractical to apply across large
groups of primates, this proposal has the potential to uncover behavioral measures that can be continuously
acquired and analyzed in real time and over a period of months to years that signal hippocampal dysfunction
with aging and neuropathology in vervet monkeys. This will open new possibilities for using this model species
to study interventions that may offset the development of Alzheimer's pathology in humans during the earliest
phases of the disease.

Public health relevance
PROJECT NARRATIVE Vervet monkeys develop age-related brain changes that resemble very early stages of Alzheimer's disease in humans. Changes in movement patterns ("wandering") are often seen in dementia and may provide a signal of mental status that can be tracked continuously and over long periods of time in vervets. We will examine movement patterns and how they relate to structure and function of a brain region involved in memory and spatial orientation, to help understand how brain aging in vervets may resemble aspects of dementia in humans and in turn help us develop new treatments and preventative measures for Alzheimer's disease.